Core C-Musculoskeletal Histology and Morphometry Core

Abstract
Histological analysis of animal and human tissues has played a key role in our understanding of development,
homeostasis, and disease in the musculoskeletal system. Fundamental histologic approaches and techniques
remain important tools for cutting-edge research projects. Additionally, the last few years have seen the
development of new methods for molecular analyses performed in situ, including spatial transcriptomics and
multiplex immunofluorescence. The complex cellular composition and location-dependent function of cells in
the skeleton make these approaches particularly attractive to researchers. However, the unique nature of
musculoskeletal tissues (e.g. calcification, unique and abundant extracellular matrix, large differences in
composition of adjacent relevant structures, etc.) renders them a substantial technical challenge.
The presence of high-quality core services enables investigators to incorporate these state-of-the-art analyses,
along with standard but expertly performed techniques, into their research programs without hiring lab staff
with histology experience. Our comprehensive approach promotes appropriate qualitative and quantitative
assessment of musculoskeletal histology while facilitating the rigor and reproducibility of core-associated
results. We continually adapt to the needs of our Research Community by meeting with investigators to assess
their needs and to provide individualized service. We also continue to work with the Washington University
Center for Cellular Imaging (WUCCI), a well-equipped microscopy resource on campus, to provide state-of-
the-art imaging options for downstream analysis of sections produced by our Core. Aim 1 – Histology services:
1) Processing, embedding, and sectioning utilizing paraffin, MMA/plastic, and frozen section approaches,
performed by Core staff; 2) 20+ routine and special stains performed in the Core; 3) Access and support for
trained users. Aim 2– Resources for Imaging and Analysis: 1) Local, in-core confocal microscope; 2) In-core
BioQuant Osteo system for histomorphometry; 3) Coordination with the Washington University Center for
Cellular Imaging. Aim 3 – Consultation, training, and development/implementation of new techniques: 1)
Individual consultation for project planning and data interpretation by Core staff and/or directors; 2)
Individualized technical training for Core equipment; 3) Technical development and support for spatial
molecular techniques; 4) Seminars and workshops. Aim 4 – Quality control and communication: 1) Support
rigor and reproducibility; and with Core A 2) Maintain website with information on services, protocols, and
didactic materials; 3) Communicate regularly with users about available services and other related resources,
and survey needs.